Understanding Maternal-Fetal Zika Virus Transmission and its Complications in Nicaragua

ABSTRACT
It has taken less than a year for the Zika virus (ZIKV) pandemic to sweep across Latin America and the
Caribbean. Over 1,000 cases have been documented in Nicaragua in the past year and active cases continue
to be identified. The virus is expected to blanket the country over the next 2-4 years. It is now clear that ZIKV
can be transmitted in utero from mother to fetus and that the consequences of congenital infection can be
severe. Although not alone among infectious pathogens in its ability to cross the placenta and cause pathology
in the developing fetus, ZIKV does present unique diagnostic challenges owing to its cross reactive serology
with other flaviviruses. In this application, we propose a series of activities that will contribute substantially to
our current understanding of maternal-fetal ZIKV infection. Through a city wide, surveillance of remnant
antenatal and delivery blood specimens in León, Nicaragua, we will study ZIKV epidemiology in this mostly
ZIKV naïve population, investigating rates of – and risk factors for – vertical transmission at the population
level. Our approach makes use of “remnant” specimens collected at delivery and during pregnancy to
categorize infants according to their ZIKV exposure and infection status. We will also test new diagnostic
protocols under development at the UNC School of Medicine, investigate the fetal/newborn immune response
to ZIKV exposure, and follow a cohort of infants for neurodevelopmental outcomes.

Public health relevance
NARRATIVE Zika virus is the only flavivirus that is known to cause birth defects, and a travel advisory remains in place in Zika endemic areas. Data is lacking on how to monitor Zika virus infections in pregnancy on a population basis. This study aims to better understand the epidemiology of Zika virus in pregnancy through a city-wide maternal and cord blood surveillance linked to antenatal blood draws and a prospective cohort of Zika exposed infants in Leon, Nicaragua.